Interrogation of the cellular and subcellular architecture of nutrient metabolism in conditions of dietary restriction

Project Summary/Abstract
The re-allocation of metabolic resources towards cell processes that promote somatic maintenance is a long-
held hypothesis to explain how diverse longevity paradigms promote healthier aging. One of the best models of
this hypothesis is dietary restriction (DR), which optimizes metabolic efficiency while maintaining animal fitness
and longevity. However, we possess surprisingly little insight into how specific nutrient resources are differentially
utilized at the cell level during DR. In addition to altering metabolic processes, DR promotes a dramatic
remodeling of organelle structures and functions. Increasingly we understand that not only is the structure of a
discrete organelle critical for its functional state, but also the spatial relationships and contact sites formed
between different organelle networks. The restructuring of the overall subcellular architecture thus plays a critical
role in determining metabolic performance. However, our preliminary data suggest that age-dependent
accumulation of molecular damage causes remodeling of the endoplasmic reticulum (ER), a hub of inter-
organellar communication. Our overarching hypothesis is thus that remodeling of inter-organelle interactions is
is both a key route by which aging cells lose functional resilience and an essential mechanism of DR-mediated
reprogramming of metabolism. To advance this hypothesis we propose to exploit new correlative electron
microscopy (EM) and stable isotope imaging technology in a combination of mouse and C. elegans models to
establish a framework for how DR restructures the organelle interactome and re-allocates nutrient flux between
organelles. Altogether this proposal aims to establish a framework for how DR remodels the organelle
interactome to promote healthy aging with a focus on the role of the ER.

Public health relevance
Project Narrative Dietary restriction (DR) is a potent and evolutionarily conserved intervention to ameliorate age-dependent disease and extend healthy lifespan. This proposal aims to elucidate new mechanisms of DR-mediated protection by determining how DR remodels the intracellular architecture to optimize inter-organelle interactions and metabolic efficiency. Understanding the mechanisms behind this structural remodeling will provide new therapeutic avenues in combating age-onset diseases.